Subzero Non-freezing preservation of whole mammalian organisms

ABSTRACT
Realizing suspended animation for humans would be transformative for the society: in long term applications where
months of preservation is needed, it would enable planetary missions to Mars and beyond. In the more immediate uses it
could be enabling for delayed resuscitation purposes in certain cases. Extended suspended animation is commonly
observed in nature including several mammalian species which hibernate at subzero environments with ambient
temperature as low as -30 ºC. While such high subzero temperatures (defined here as 0 ºC to -30 ºC) is utilized commonly
by nature as a means to establish whole organism preservation for extended durations, subzero non-freezing preservation
has not been explored for mammalians in literature (see Significance) and remain a profitable area for research.
Our overarching goal is to push the boundaries of scientific discovery by enabling metabolic stasis and reanimation
for an organism without the natural capacity for suspended animation. The objective of this NIGMS exploratory research
grant for technology development is to test the viability of sub-zero, non-freezing (SZNF) storage of a mammal for the
first time in literature. The studies would also lead to preliminary data in a context where none exists, which in turn would
enable continuation with a more traditional funding mechanism once the risks are reduced and mechanistic targets are
identified to enable hypothesis driven research. This objective was formulated based on our team's prior success in
scaling subzero nonfreezing preservation to human livers, which provided us with key new technologies enabling control
of intracellular carbohydrate levels, understanding of endothelial sensitivity to ischemia and strategies for mitigation, and
machine-assisted recovery/reanimation techniques to ameliorate preservation injury. However, the transition from a single
organ to an entire mammalian organism presents a vertical step forward, a potential breakthrough but with considerable
risk. As such, this technology design-directed proposal specifically matches the program requirements for this exploratory
grant mechanism.
As a result of these studies, we expect to develop novel technologies that enables preservation of neonatal and post-
natal mice in subzero temperatures. To do so, we aim to develop several novel protocols and cryopreservatives to avoid
freezing in the context of whole-organism storage. These results are expected to lead to preliminary data that shows
survival after days of subzero storage, which will motivate future research, as well as key data that will enable formulation
of new hypotheses that will enable the utilization of more traditional funding mechanisms.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Whole organism suspended animation could transform trauma medicine from a race against time to planned surgical care, and could be enabling for planetary missions. Although whole human suspended animation is currently impossible, naturally occurring suspended animation occurs in seven different orders of mammals, suggesting that this phenotype arises from molecular pathways present in all mammals, including humans. The objective of this exploratory research grant application is to test the viability of sub-zero, non-freezing storage of a mammal for the first time in literature.